Leveraging the electronic health record to characterize and optimize care delivery for children with cerebral palsy.

Abstract/summary
Leveraging the electronic health record to characterize and optimize care delivery for children
with cerebral palsy: Cerebral palsy (CP) is the most common physical disability of childhood, but it is highly
heterogeneous with respect to its severity, response to therapy, care needs, and impact on wellness
for the child and family. To optimize health and wellness throughout life and enable new research
avenues to be effectively tested, it is critical to develop a comprehensive clinical care and
biopsychosocial data model. Development of a comprehensive model would both accelerate and improve
understanding, care, and further research, including the identification of novel targets for
interventions. The overriding objective of this proposal is to develop a precision health model for CP-related phenotypes, health status, care activities, and psychosocial well-being that will individualize care. To accomplish this objective, we will automate the collection, cleaning, and integration of multi-dimensional, multi-domain and multi-cohort based "big data" extracted from the electronic health record (EHR), and combine this EHR data with prospectively
collected, high-resolution clinical, functional, environmental and psychosocial data. The focus of this proposal will be on children between ages 6 and 12 years. Preliminary work indicates that the medical center provides care for
approximately 1,800 patients with CP who are between the ages of 6 and 12 years and have at least
three years of EHR data. From this EHR cohort, we will prospectively recruit 200 children and their
families for detailed phenotyping.
Recruitment will be stratified by Gross Motor Functional Classification System (GMFCS) Levels: 60%
GMFCS I, II, or III (able to walk) and 40% GMFCS IV or V (use a wheelchair). Using this
multi-cohort design will allow for robust characterization of multi-dimensional factors that impact care receipt, functional
outcomes, quality of life and participation. Aim 1 will focus on creating a diverse and comprehensive data repository
using both retrospective and prospective data to characterize actual versus optimal care (defined
by current evidence-based literature). Aim 2 will lead to development of a receipt of care
coefficient score and characterize how the degree of optimal care relates to function, quality of
life and participation, controlling for functional status and age. [Models developed in Aim 2 will
be translated into a clinical decision tool prototype. Aim 3 will demonstrate proof of concept for
scalability of machine learning algorithms with the PEDSnet Learning Health System. This project
innovatively combines retrospective EHR data with prospective clinical data to elucidate
individual, treatment, family, and environmental factors associated with greater receipt of
evidence-based care and/or better outcomes. This project will move the field toward precision
medicine for CP and create a foundation for development of clinical dashboards to optimize practice.]

Public health relevance
Project Narrative The proposed project innovatively applies machine learning methods to retrospective electronic health record and prospective clinical data to develop a precision health model for cerebral palsy-related phenotypes, health status, care activities, and psychosocial well-being that will individualize care. This project will move the field toward precision medicine for cerebral palsy and create a foundation for development of electronic health record-based clinical practice tools. The proposed research is highly relevant to the NIH mission to understand and enhance the lives of children and optimize abilities for all.